Core A: Administration

PROJECT SUMMARY - CORE A
Core A provides administrative support to the Program as a whole, and manages its vibrant external seminar
series. Importantly, Core A also provides computational support for the program, particularly by maintaining
program databases, by educating program personal in the use of available computational tools, and by
developing customized analysis pipelines within the Galaxy environment. Core A provides access as needed
to high-end computational collaborators to address the more exotic informatics problems faced by Program
investigators. Finally, Core A provides training for postdoctoral fellows and student in reproducibility and rigor
in experimental approaches.